Chemistry-Biology Interface Training Program

PROJECT SUMMARY/ABSTRACT
This proposal outlines a comprehensive plan for graduate education in chemistry & biology at UW–Madison
via the Chemistry-Biology Interface training (CBIT) program. We seek to provide cross-disciplinary research
training to our students, so that chemists and biologists not only appreciate, but also use, the tools and
techniques developed by each other. These types of fresh approaches can lead to meaningful and truly
impactful breakthroughs in science. The overall objective of CBIT is to educate trainees so they understand and
can articulate scientiﬁc problems that span the chemistry–biology interface, have the technical skills to realize
an independent research project at this interface, and can communicate their discoveries to diverse audiences.
CBIT’s speciﬁc objective is to maximize Ph.D. completion rates within our 5 core departments/programs and
measure longitudinal student outcomes (as per degree completion and job placement in the biomedical
workforce) that will advance best practices in biomedical graduate training overall. CBIT’s overall & speciﬁc
objectives are shaped by our mission to cultivate an inclusive, safe, and engaged community of
cross-disciplinary scholars that is fostered by strong communication and teamwork. To realize these
objectives, we request funds to support the CBIT program at the level of 10 trainees/year, with each trainee
funded for 2 years. Key features of our proposed program are underscored below:
● The CBIT program will provide an integrated set of coursework (foundational and area speciﬁc, with
dedicated courses in ethics and research rigor), research experiences that span the frontiers of the chemical
biology ﬁeld, mentorship training, focused training in communication (with mentors, other scientists, and
the public), substantive career development opportunities (internships, annual workshops, and IDPs), and
team-based and community-building experiences (via courses, research, and outreach).
● We will provide trainees a pale e of four professional skill sets aligned with diﬀerent biomedical careers
(academic, industry, government, and legal/non-proﬁt), guided by the needs of current employers within
the biomedical workforce (via consultation with our new External Advisory Board), and composed of
diﬀerent activities that are speciﬁcally tailored for success in these four career spaces.
● We will evaluate our ability to achieve these results through quantitative assessments of the outcomes of
the CBIT program, including gains in science identity, science self-eﬃcacy, and core graduate school
competencies such as broad knowledge of a discipline, experimental skills, and critical thinking skills.
Our CBIT program ﬁlls a unique niche at UW–Madison as the only T32 program centered in the chemical
sciences. This interfacial program has signiﬁcantly impacted student outcomes—notably, of our 57 CBIT
Ph.D. graduates since 2008, 55 (96%) are in careers that directly impact human health. We will build on this
strong history and continue to innovate in graduate education over the next 5 years.

Public health relevance
PROJECT NARRATIVE The Chemistry-Biology Interface Training (CBIT) Program is a unique graduate training program at the University of Wisconsin–Madison centered on an appreciation of the blending of chemical and biological methods to solve biomedical problems. The mission of the CBIT Program is to educate graduate students to recognize and address these problems using innovative and rigorous approaches, to provide professional development skills and career mentorship that will allow them to succeed and lead in the biomedical workforce, and to cultivate an inclusive, safe, and engaged community of cross-disciplinary scholars that is fostered by strong communication and teamwork. This focus on both interfacial research training and community will a ract and retain students, and is ideal preparation for designing, discovering, and developing the next generation of therapies that will directly impact human health.